Community Engagement Core

PROJECT SUMMARY – COMMUNITY ENGAGEMENT CORE
Arkansas has persistent and profound cancer and cardiovascular disease disparities in rural low resource counties
and among Blacks/African Americans. Efforts to eliminate these place- and race-based disparities must include
residents who are most affected, in addition to caregivers, practitioners, policy makers, academicians, and other
stakeholders. The Community Engagement Core of the Center for Research, Health and Social Justice builds
on the solid researcher-community partner engagement history established by the Arkansas Center for Health
Disparities, the Office of Community-Based Public Health, and the Translational Research Institute's Community
Engagement Core at the University of Arkansas for Medical Sciences. The goal of the Community Engagement
Core is to maintain and expand a broad-based coalition of regional stakeholders who are engaged in partnerships
that result in novel chronic disease health disparities research whose results are disseminated and translated to
inform sustainable community and systems-level changes. The Community Engagement Core will create a critical
mass of community-academic partnerships that have the skills and capacity to engage in research from idea
conceptualization to translation of relevant research findings. The Core will expand its coalition of partners in
the Northwest, Highlands, and Delta rural regions of the state through its annual Community Campus Partnership
Conference, career enhancement activities and the Community Based Organization Capacity Training. The
Community and Institutional Advisory Boards will provide consultations to academic researchers to facilitate new
equitable community-academic partnerships that result in novel and cultural relevant funded research in
collaboration with the Investigator Development Core. In collaboration with the Administrative Core, the
Community Engagement Core will use concept mapping, geographic information system mapping, and
community asset mapping to inform strategic plans for dissemination and translation. Our mixed-methods are
grounded in the National Institute on Minority Health and Health Disparities Research Framework, the
Knowledge to Action Framework, the Integrated Framework for Community Engagement, and social justice
principles. The Core seeks social justice by promoting fairness, equity and diversity in participation in research,
equitable access to skills building and networking opportunities, and shared decision-making that builds trust,
improves the utility of research results, and ultimately improves the human right to health. It is expected that the
Core's synergistic approaches will result in research findings that translate into changes in systems, policies,
and environments that eliminate chronic disease health disparities in our target regions and beyond.